User Training & Outreach

The primary goals of the GM/CA@APS Training and Outreach Core are to train users about the advanced
technologies offered by the GM/CA macromolecular crystallography resource, to reach out to the
scientific community with information about GM/CA technologies, to promote and disseminate advances,
and to increase diverse perspectives in a broadened scientific user base. Dr. Janet Smith (PI) leads the
Training and Outreach Core; most GM/CA staff have roles in one or more aspects of training and
outreach. Training of both remote and on-site users is achieved through personal interactions with
GM/CA staff hosts, as well as through videos and documentation available at the GM/CA website. The
on-line materials are updated frequently to keep pace with the growing sophistication of the PyBluIce
user interface and the associated data processing pipelines. An important goal is to reach out to the user
community with information and training about the new capabilities that will be available with the orders-
of-magnitude brighter X-ray beam of the upgraded APS. To provide in-depth training on these major
advances to our existing user community in ways that also engage the rich diversity of the potential user
base, we will host on-site, reverse-site, and remote (virtual) Mini-Workshops in which GM/CA staff
engage with several user groups simultaneously to provide detailed training. We will continue to host the
successful annual CCP4/APS School for Macromolecular Crystallography, now in its sixteenth year,
which has been demonstrably effective in training users. We will continue general outreach to the
scientific community through staff attendance and presentations at scientific conferences and
publications, and will seek to lead workshops and sessions associated with various meetings and venues.
Advances will be disseminated further via publications and sharing of software and technologies. A
proactive outreach effort will seek to engage, train and enable scientists with diverse perspectives. We
will also promote the GM/CA Resource and user science by highlighting significant user results through
our website and the APS and Argonne communications offices.
1